Global Health Emerging Scholars Program

PROGRAM SUMMARY
The objective of our LAUNCH program is to continue our global health research training program called the
Global Health Equity Scholars (GHES) designed to create a new community of researchers, educators, and
professionals who are prepared to address new and emerging global health challenges. We will build on the
last nine years of this training program to create a cadre of new researchers who will dedicate their research
careers to address the health problems that arise out of the inequity of human conditions prevalent in
informal human settlements (slums). Rather than addressing one disease at a time, we propose to provide a
comprehensive, multidisciplinary and integrated approach to deal with urban and rural informal human
settlement health issues, developed over many years by the participating faculty members of this program.
This program will comprise four US partner institutions (Consortium)--Yale University, Stanford University,
University of Arizona, and University of California at Berkeley, each led by a leader in global health research
with more than 10 years of collaboration among themselves. Together, core faculty mentors from these
institutions conduct research at 25 institutions in 21 countries, representing regions of Africa, Central and
South America, the Caribbean; Asia, the Pacific, and Eastern Europe. The GHES program will address a
wide range of health research topics including HIV/AIDs, emerging and high- consequence infectious
diseases, non-communicable diseases (NCD), women’s health, environmental health, mental health,
interpersonal violence, substance abuse, injuries, and the interaction of all of these health issues within the
framework of slum health. Training will target US postdoctoral fellows and pre- doctoral students and low
and middle-income country (LMIC) postdoctoral fellows. We plan to recruit 9-10 trainees/year with 60% of
them as US postdoctoral fellows. The trainees will spend 8-12-months at an LMIC site under the supervision
of the Consortium and their collaborating LMIC mentors. Didactic workshops on global health research
methods will be conducted both in-person and online. LMIC trainees will spend 2-3 months at US institutions
to undergo training in methods not provided at their institutions. All of the trainees will be provided with
research and career mentorship throughout their training and tracked for career development after
completion of their GHES-supported research work. Thus, under this program, we expect the trainees to be
exposed to one important theme in global health research--health equity--through research that deals with
health concerns of vulnerable populations residing in informal human settlements, and provide them with an
opportunity to become experts in this new global health discipline. The overall impact of this training program
is, therefore, to create a new cadre of global health researchers and leaders who address the emerging
health issues arising out of ever-expanding informal human settlements of LMICs.

Public health relevance
Public Health Relevance Statement (Program Narrative): “This training program is specifically designed to train a new cadre of researchers and leaders to address major but under-studied public health problems arising from conditions prevalent in urban and rural communities in low- and middle-income countries (LMIC). This training is relevant also to developed countries as populations face increasing barriers to stable housing and healthcare. Selected candidates will undergo field training on site in LMICs to develop new global health research skills framed within our project research theme of strengthening health systems.